Predictive modeling for social needs in emergency department settings

Unmet social needs create immediate risks to health, increase utilization, wait times and costs, and contribute
to provider burnout. Due to the high prevalence of unmet social needs such as housing or income insecurity
among patients, the emergency department (ED) is an opportune setting for intervention. Problematically, social
needs frequently go unscreened and unaddressed in EDs. Basic workflow issues and time constraints inhibit
screening. Patients may decline screening or avoid questions they deem stigmatizing. While numerous ques-
tionnaires exist to screen for a broad number of social needs, their reliability and validity are unknown. Predictive
modeling combined with clinical decision support (CDS) could overcome the above challenges that limit screen-
ing and perpetuate ED patients' unmet social needs. Our long-term goal is to support effective care by enabling
provider access to clinical and social context information. The objective of this proposal is to implement and
evaluate a CDS tool that identifies ED patients needing a referral to the social providers best equipped to address
social needs. Our central hypothesis is that the purpose of screening is to inform referrals to appropriate services
and that, in the context of social needs, social workers, dietitians, and behavioral health counselors are the
professionals best suited to meet patients' needs. Leveraging a proven technological infrastructure and collabo-
ration with an urban, safety-net ED, this project will accomplish three aims. Aim 1, Compare the effectiveness of
predictive modeling vs. questionnaire-based screening in identifying patients in need of social and behavioral
services, compares the performance of predictive modeling against questionnaire-based screening. Predictive
modeling will leverage a unique combination electronic health record, health information exchange, social ser-
vice organization, and public health data sources. Aim 2, Identify ED providers' and patients' perceptions of
screening for unmet social needs using predictive modeling and questionnaire-based screening, utilizes qualita-
tive methods grounded in implementation and patient-centered innovation theoretical frameworks to understand
ED patient, provider, and staff perceptions of enablers and barriers to screening. Aim 3, Quantify the impact of
real-time screening for social needs on subsequent utilization, will implement and evaluate a CDS intervention
(using the best performing approach from Aim 1 and guided by the findings of Aim 3) that facilitates appropriate
referrals to social and behavioral providers in a pre-post with comparison group longitudinal design. Outcomes
of interest are reduced ED revisits, increase follow-up visits with primary care providers. The proposed research
is significant because it directly compares two approaches to addressing the widespread problem of unmet social
needs. This proposal is innovative by applying predictive modeling with personal, social service, and clinical
context data, and by shifting social screening research to the ED. By working with an urban safety-net hospital,
this research addresses the priority populations of socioeconomically disadvantaged and minority populations
who are disproportionality burdened by unmet social needs.

Public health relevance
The proposed research is relevant to public health because unmet social needs negatively influence health, increase utilization, perpetuate disparities, and increase health care costs. The proposed research is relevant to AHRQ's mission to safer, higher quality, and more affordable care by supporting efficient and effective delivery of services.